Posttranslational Regulation of FOXA1 in Breast Cancer

Project Summary
Breast cancer is the second leading cause of cancer mortality in women and nearly 75% of all breast
tumors express estrogen receptor alpha (ER) at the time of diagnosis. Despite the therapeutic successes of
endocrine therapies designed to target ER function, about 30-40% of tumors become resistant to endocrine
therapy, either through de novo or acquired resistance, and still retain the expression of ER. Herein we propose
to study the regulation of FOXA1, a pioneer transcription factor that enables ER binding to chromatin, whose
theoretical inhibition would circumvent known mechanisms of endocrine therapy resistance. In breast cancer,
FOXA1 is responsible for almost all of the ER binding events in the genome and its upregulation is associated
with enhancer reprograming in endocrine resistance. However, there is a paucity of information about how
FOXA1 itself is regulated and how cancer cells repurpose its pioneering activities to drive oncogenesis.
To this end, our lab has been studying the crosstalk between the endocrine and immune systems in
breast cancer. We have discovered that FOXA1, in response to the proinflammatory cytokines, is driven to non-
canonical sites across the genome to promote chromatin accessibility for estrogen-liganded ER. These newly
formed enhancers were found in compacted/latent regions of the genome and promoted the expression of a
novel gene set that was predictive of poor clinical outcomes in patients. Concurrently, we discovered that FOXA1
is post-translationally modified (PTM) in response to proinflammatory cytokines at two evolutionarily conserved
amino acids. The post-translational modification of FOXA1 in response to external stimuli has not been shown
before and suggests an important mechanism that underlies FOXA1 regulation and function. Therefore, the
overall goal of this project is to determine the molecular events that allow proinflammatory signaling to alter
endocrine signaling through modulation of FOXA1 function and the biological consequences of this crosstalk.
We hypothesize that estrogen- and TNFα-directed PTMs of FOXA1 dictate binding site selection, driving ERα
to non-canonical enhancers across the genome, leading to expression programs that underlie the tumorigenesis
of breast cancer. To systematically test this hypothesis, will use an integrated set of molecular, genomic, and
proteomic approaches to: (Aim 1) define the role of FOXA1 PTMs on its pioneering function and chromatin
occupancy, (Aim 2) identify the writers and readers of FOXA1 PTMs, and (Aim 3) understand inflammation-
based modulation of FOXA1 independent of PTMs. We will perform these experiments in breast cancer cell
lines, ER+ patient-derived xenografts (PDX), and in ER+ mature luminal cells isolated from patient tumors. The
dependence on FOXA1 for hormone receptor signaling makes it an attractive therapeutic target. While there are
currently no known inhibitors of FOXA1 and its protein structure makes it difficult to target therapeutically, our
ability to understand basic molecular mechanisms is directly correlated with our ability to develop better
therapeutic interventions. Defining how FOXA1 is regulated becomes key to this endeavor.

Public health relevance
Project Narrative In estrogen receptor positive breast cancer, crosstalk between inflammatory signaling and estrogen signaling play key roles in promoting more aggressive tumors and resistance to hormone therapy. Herein we propose to study the regulation of FOXA1, a pioneer transcription factor that enables estrogen receptor binding to the genome, whose theoretical inhibition would circumvent known mechanisms of endocrine therapy resistance. The mechanisms elucidated by this study will elaborate a facet of breast cancer biology that remains unexplored and has potential to change the way we think about, diagnose, and treat breast cancers.